BOTULINUM TREATMENT OF STRABISMUS--BASIC MECHANISMS

Botulinum A toxin (BTX) paralyzes neuromuscular transmission by blocking release of acetylcholine from nerve terminals. In recent years, small quantities of BTX have been injected into extraocular muscle of strabismic humans to induce corrective changes in ocular alignment. For many patients, the corrective changes in ocular alignment persist long after the direct paralytic effects of BTX have worn off. These findings suggest that peripheral or central adaptive processes, triggered by BTX paralysis, induce ocular alignment. Despite extensive clinical experience with BTX, however, the nature of these processes is obscure. This study will employ a multidisciplinary approach designed to identify and study the character of these adaptations. The study will examine infant and adult animal models of strabismus as well as human patients selected for BTX therapy. Five specific experiments are planned: 1) To measure passive orbital stiffness and hysteresis in adult and infant monkeys. Preliminary studies in our laboratory suggest that orbital stiffness changes are sensitive indicators of structural changes in the globe-muscle system. 2) To create a clinically relevant animal model of strabismus by performing myectomies of a horizontal rectus muscle. This model will be used to study the effects of BTX treatment to relieve or prevent muscle contracture. 3) To analyze binocular eye movement patterns in monkeys after myectomy and/or BTX treatment. 4) To study ultrastructure in paired agonist-antagonist extraocular muscles after BTX treatment. 5) To compare and study eye movements of human patients treated with BTX. Taken together, our findings should provide significant insights into central and peripheral adaptive mechanisms relevant to the development of strabismus, and its treatment by BTX therapy.